Preparation for lung transplant discussions and decisions among people with cystic fibrosis

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of
text.
Cystic fibrosis (CF) is a progressive, fatal genetic condition (median age at death was 34 years in 2020). Lung transplant
(LTx) is a treatment for end-stage CF and confers 10 years median survival for adults with CF. In the U.S., among CF
patients with forced expiratory volume in 1 second (FEV1) less than 30% of predicted, more patients die each year than
undergo LTx. More than half of CF patients who die without LTx are never referred for consideration. Patient preference
may account for 25-40% of decisions to defer referral, but choices may at times be informed by inaccurate assumptions
regarding LTx. CF patients with low FEV1 have high rates of anxiety and depression, which may contribute to avoidance
of LTx conversations. Increasing LTx comprehension, and promoting the process of deliberation, could reduce the
number of people with CF who die without LTx.
We collaborated with CF patients, caregivers, and physicians to develop Take on Transplant (ToT): a web-based, patientfacing
resource for LTx education. ToT shares personal narratives of CF patients and caregivers and up-to-date, CFspecific,
guideline-based medical information about LTx. The overall research objectives are to test the efficacy of ToT
compared to an attention control in a multicenter randomized clinical trial incorporating mixed methods to assess
preparedness for LTx discussions among all CF patients with FEV1 <50% predicted, explore the impact of ToT on
patients’ psychosocial functioning, and assess patients’ and physicians’ perceptions and use of LTx education. Our
research will examine patient-physician interactions and explore factors that may determine if/when physicians discuss
LTx with CF patients and the impact of ToT on patients’ readiness for LTx discussions.
We aim to empower all CF patients to discuss LTx. The proposed R01 will test the impact of ToT on preparedness for LTx
discussions and will evaluate patient-physician dynamics that may impact access to LTx in the CF population.

Public health relevance
Our work aims to promote access to lung transplant for all members of the cystic fibrosis population using up-to-date, cystic fibrosis-specific lung transplant education that supports self-efficacy and patient-empowerment in health care decisions. High-quality lung transplant discussions could improve clinical and psychological outcomes by changing attitudes, beliefs, and choices related to transplant. The Take on Transplant lung transplant decision support tool has the potential to expand the toolbox for engaging patients with cystic fibrosis in high-quality lung transplant discussions and improve access to transplant for all people with cystic fibrosis.